Roles of m6A mRNA Methylation in Innate Immunity

PROJECT SUMMARY/ABSTRACT
Post-transcriptional modifications of mRNA have emerged as a central regulatory mechanism in genetic
information flow. N6-methyladenosine (m6A) is the most abundant post-transcriptional modification in
eukaryotic mRNAs. m6A mRNA methylation is reversible and dynamically regulated by writers, erasers and
readers. Writers are methyltransferases that install the methyl group on adenosine residues, erasers are
demethylases that remove the methyl group, and readers are proteins that recognize and interact with the m6A
site. m6A methylation influences all fundamental aspects of mRNA metabolism, including mRNA processing,
stability and translation. Despite tremendous progresses, the in vivo roles of m6A mRNA methylation in
macrophage biology remains unclear. Sepsis is a major clinical problem and leading cause of death in patients
in intensive care units. Sepsis is usually caused by Gram-negative bacterial infection that triggers a fast
cytokine storm. Macrophages as the first line of defense are the predominant producer of pro-inflammatory
cytokines during infection. Proper resolution of the cytokine response is essential for the host's well-being. The
intensity and duration of cytokine storm is delicately regulated by negative feedback regulatory loops, and the
SOCS family of proteins are the central players of this feedback regulatory mechanism. We have sought to
understand the role of m6A methylation in macrophage biology by genetically targeting METTL14, a core
subunit of the m6A methyltransferase (a writer). We found that mice carrying METTL14 deletion in myeloid
cells are hypersensitive in both cecal ligation puncture (CLP)- and lipopolysaccharide (LPS)-induced sepsis
models. These tissue-specific METTL14-mutant mice produced and maintained much higher levels of serum
pro-inflammatory cytokines and suffered much higher mortality than control mice. METTL14-depleted
macrophages produced and sustained much higher levels of pro-inflammatory cytokines than the control
macrophages, and the underlying cause is that METTL14 deletion impairs SOCS1 induction in macrophages
following bacterial infection or LPS challenge. Our data support the hypothesis that m6A methylation plays a
critical role in controlling the intensity and resolution of cytokine storm in sepsis by increasing Socs1 mRNA
stability and translation. Our data strongly suggest that LPS or bacterial infection activates the NF-κB pathway
that stimulates Socs1 mRNA transcription; LPS/bacterial infection further increases Socs1 m6A methylation by
promoting FTO (an eraser) mRNA degradation, and then YTHDF1 (a reader) binds to the Socs1 m6A sites to
promote Socs1 mRNA stability and increase its translation. In this proposal we will validate that SOCS1 is an
essential METTL14 target to control macrophage activation in septic response using in vivo and in vitro models
(Aim 1), validate that YTHDF1 is a critical reader to promote Socs1 mRNA stability and translation in septic
response (Aim 2), and validate that FTO is a critical eraser whose mRNA degradation promotes Socs1 m6A
methylation and greatly contributes to negative feedback control of macrophage activation (Aim 3).

Public health relevance
PROJECT NARRATIVE N6-methyladenosine (m6A) is the most abundant post-transcriptional modification of eukaryotic mRNAs. In vitro studies have demonstrated that m6A modification influences all fundamental aspects of mRNA metabolism, but its in vivo functions in mammalian physiology remain elusive. The role of m6A mRNA methylation in innate immunity, particularly in macrophage activation, is completely unknown. In this application we will investigate the mechanism whereby macrophage m6A mRNA methylation regulates innate immunity in the context of acute inflammatory stress (i.e. sepsis).